Mass Spectrometry and Molecular Biology Module

Mass Spectrometry and Molecular Biology Module
Abstract
The objective of the Mass Spectrometry and Molecular Biology Module is to enhance the capabilities of
individual investigators to conduct cutting edge research in the vision sciences. Our Aims are: 1) to provide
resources, support and training required for conducting studies involving mass spectrometry, molecular and
cell biology techniques at the level exceeding the capabilities of any individual laboratory; 2) to promote
collegiality across the community of vision scientists through sharing resources, techniques and expertise; and
3) to engage colleagues into conducting vision research, including support of the next generation of basic and
clinician scientists. To achieve these Aims, this Module will support sophisticated facilities equipped with state-
of-the-art instrumentation and cutting edge software support. The Module will be supervised and operated by
highly experienced personnel, with expertise in conducting a broad array of mass spectrometry and other
molecular techniques, including but not limited to proteomics, mass spectrometry of small molecules, RT-PCR,
quantitative fluorescent imaging and tissue culture. These shared resources will open new research
possibilities for both experienced and novice users, and will serve as a platform for fostering interactions
among a broad swath of our research community.